Predicting Functional Decline and Clinical Outcomes in Newly Diagnosed Older Patients with Localized Bladder Cancer

PROJECT SUMMARY/ABSTRACT:
Older patients with cancer are disproportionately perceived as unfit for aggressive therapies, resulting in
significantly lower rates of definitive cancer care and poor outcomes. We lack validated tools to reliably predict
personalized risks of adverse treatment-related events and salient outcomes for older patients such as functional
decline. While guidelines advocate for widespread adoption of Geriatric Assessments (GAs) to quantify
multidimensional vulnerabilities prior to treatment decision-making in older patients with cancer, clinical adoption
is low related to a dearth of data evaluating the ability of GAs in clinical practice to discriminate those at risk for
functional decline, adverse clinical and oncologic outcomes. Furthermore, traditional GAs do not include
validated metrics of muscle mass that independently predict clinical and oncologic outcomes. Bladder cancer is
an ideal health condition in which to evaluate and develop personalized geriatric oncology risk stratification tools,
given median age at diagnosis of 73 years, a high baseline prevalence of comorbidities, substantial risk of
treatment-associated adverse events, and universal lethality if untreated. Our objective is to quantify functional
decline in patients with newly diagnosed bladder cancer, and to develop prediction models incorporating GA-
based frailty and muscle metrics for the outcomes of functional decline, treatment-associated morbidity and
mortality. The Specific Aims are: (1A) To characterize prevalence and predictors of functional decline in older
adults with newly diagnosed bladder cancer, (1B) to determine if baseline frailty and muscle metrics predict
functional decline, and (2) To evaluate associations frailty, muscle metrics, and treatment-associated outcomes
(i.e., adverse events, survival) in older adults with localized high-risk bladder cancer. To achieve Aim 1, baseline
functional status will be compared with a 3-month assessment in a prospective newly diagnosed older bladder
cancer cohort (N=250) undergoing a pretreatment GA-based frailty self-assessment and muscle metrics and a
predictive model will be developed. For Aim 2, we will construct multivariable models for treatment-associated
adverse events, postoperative complications, and mortality incorporating GA-based frailty and muscle metrics
from a robust bladder cancer registry. This innovative study advances risk stratification by incorporating validated
GA tools augmented with robust body composition data. This work is significant: it will be the first study to
characterize risk factors for functional decline in older bladder cancer patients, while addressing the acute need
to validate rigorous personalized risk stratification tools incorporating geriatric conditions to inform treatment
decisions, ensuring alignment with patient priorities. This work will directly translate to improvements in outcomes
of older patients with cancer and extrapolate to other malignancies. This GEMSSTAR project, mentoring
committee, and professional development plan will help the PI to become one of the few independent
investigators with expertise intersecting aging, urologic oncology, and patient-centered outcomes research.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because more accurately characterizing and quantifying functional decline and salient clinical risks in newly diagnosed older patients with cancer will help align treatment decision-making with personal preferences and improved health outcomes. This research is relevant to the 70 million older adults who will be diagnosed with cancer in the coming years and aligns with the NIA’s goal to develop methods to empirically measure comprehensive risk incorporating geriatric conditions such as multimorbidity, cognitive and functional frailty, as well as innovative risk stratification measures such as muscle mass and quality that have demonstrated predictive utility for clinical outcomes and which can be obtained from routine staging imaging.